RESEARCH IN STATISTICS

This project addresses statistical problems generated from collaboration with scientists in other program areas and general statistical problems of current interest encountered in biomedical research. This project is a continuing activity of the Branch. In FY97, Branch statisticians have contributed to the following areas of statistical research: screening methodology for diseases in general populations; measurement of structural uncertainties in morbidity data arising from the choice of disease definition; investigation of selection bias in epidemiological surveys; derivation of nonparametric techniques for sample size estimates for MS clinical trials based on historical longitudinal data; development of a generalized estimating equation approach for the analysis of spatially correlated binary data and determination of the size of cell populations; the application of receiver operator characteristics methods for the classification of subjects at increased risk for neurological disease; development of statistical methods for the analysis of sensitivity, specificity, and predictive value of diagnostic tests; and the application of recursive partitioning for the evaluation of risk factors in epidemiological studies. Other active areas of statistical research are: the development of nonlinear response models when response is nondecreasing and is a time-dependent function of two compartments; statistical modeling of longitudinal data to identify bench mark events and their time of occurrence in the clinical course of disease; adapting analysis methods for the estimating the level of disease risk for individual factors in the presence of many correlated potential risk factors; and the formulation of analysis methods for survival data with time- dependent covariates, the presence of competing risks, and informative censoring.